Functional consequences of heterotypic retinal ganglion cell coupling

Neurons communicate using both chemical transmission at traditional synapses and electrical transmission
through gap junctions. Electrical transmission is well studied in the mammalian retina, where gap junctions
exist between all five major classes of neurons. Retinal ganglion cells (RGCs), the output cells of the retina,
comprise ~40 functional types in mammals. Gap junctional coupling among RGCs has always been described
as “homotypic,” that is, between RGCs of the same type. We have discovered, for the first time, heterotypic
electrical coupling in the mouse retina, between two RGCs of different types, called F-miniON and F-miniOFF
RGCs.
The existence of heterotypic RGC coupling breaks the rule of functional parallelism between RGC channels
and requires new ideas about the role of coupling in retinal computation. This project aims to explore the
functional role of heterotypic RGC coupling in the F-mini network through two specific aims. In Aim 1 we will
determine whether coupling between F-miniON and F-miniOFF RGCs creates a novel pathway for mixing ON and
OFF signals in the inner retina. In Aim 2 we will determine which features of moving stimuli are encoded by
synchronized spiking between F-miniON and F-miniOFF RGCs.
The proposed studies will advance our understanding of how chemical and electrical synaptic inputs interact to
perform neural computations and how sharing of signals between parallel pathways contributes to sensory
encoding.

Public health relevance
The goal of our research is to discover the mechanisms of visual computation in the retina. This proposal studies a novel circuit in two different types of retinal ganglion cells are electrically coupled. Our discovery of heterotypic coupling in retinal ganglion cells, the output cells of the retina, challenges a long-standing principle of functional parallelism, requiring new ideas about early stages of visual computation. This research will have impacts beyond the retina in revealing fundamental principles of neural circuit architecture and mechanism in line with the goals of the BRAIN initiative.